Impact of State and Federal Contraceptive Coverage Policies on Contraceptive Use, Costs, and Pregnancy Outcomes

Abstract
This project seeks to understand how state and federal policies requiring health insurers to cover prescription
contraceptives have impacted both intermediate and long-term public health outcomes. Intermediate outcomes
include out-of-pocket spending on contraception and contraceptive use; long-term outcomes include
pregnancy spacing and adverse pregnancy outcomes. This research is important because both federal and
state-level policymaking have addressed contraceptive coverage in recent years, yet contraceptive coverage
policies continue to be challenged and the lack of information about policy impact hampers efforts to address
the long-term public health policy goal of reducing unintended pregnancies and their consequences.
At the federal level, the Patient Protection and Affordable Care Act (ACA) required most private health plans to
provide no-cost coverage for all FDA-approved contraceptive methods beginning in August 2012, a benefit
already provided to publicly-insured women. Prior to the ACA, 28 states and D.C. required health plans to
provide some degree of contraceptive coverage; following the ACA, 11 of those states required no-cost
contraceptive coverage. Over the past 20 years, 33 states have obtained waivers to expand eligibility for family
planning services under Medicaid. Finally, the ACA also allowed for Medicaid expansion, which has been
implemented in 34 states and D.C. to date, thereby increasing the number of low-income women with access
to no-cost contraceptive coverage. We propose studying the impact of these contraceptive coverage policies
using a difference-in-differences analyses, which will examine key outcomes for populations over time by
comparing those exposed and not exposed to coverage policies. We will use the MarketScan® Commercial
Claims and Encounters database which includes health care utilization information on approximately 50 million
privately insured individuals per year and Medicaid data to determine how the implementation of state and
federal contraceptive coverage policies impact: 1) out-of-pocket spending for contraceptives; 2) use of specific
contraceptive methods and method adherence; and 3) interpregnancy intervals, preterm birth, and low
birthweight. This study will provide needed data to inform policymaking at the state and federal levels on the
impact of contraceptive coverage policies on key public health outcomes. It expands prior research in the
scope of the population studied, the range of policies studied, and the outcomes investigated. Findings will
indicate the extent to which contraceptive coverage policies are an effective tool for achieving the
HealthyPeople family planning goals of improving pregnancy planning and spacing, and preventing unintended
pregnancy.

Public health relevance
Narrative In recent years, several state and federal policies have been implemented that require insurance coverage for contraception. The proposed study will use data from a national sample of privately insured women (MarketScan® Commercial Claims and Encounters database) and publicly insured (Medicaid) women to determine how these policies have affected contraceptive spending, contraceptive use and adherence, and adverse pregnancy outcomes in the U.S. This study will provide key data needed to inform policymaking at the state and federal levels on the impact of contraceptive coverage policies.